Vascular Surgery Research Training (VascTrain)

This application is the third renewal application for the Vascular Surgery Research Training (VascTrain)
T32 Program. The VascTrain T32 program was established in 2010 to enhance clinically relevant basic,
translational, and clinical research in vascular surgery trainees and nonclinician trainees with a specific interest
in the study of vascular disease and its treatment. The program supports 3 training positions each year (6 total
positions) with 2 positions designated for vascular surgery residents and the third position for a trainee from
general surgery or a nonMD post-doctoral fellow. The same number and distribution of positions are being
requested in the current application. The training faculty is composed of 23 trainers from a number of
Departments including Surgery, Cardiac Surgery, Plastic Surgery, Bioengineering, Chemical Engineering, the
CTSI, Critical Care Medicine, Medicine, and Anesthesia. The mentors have been selected for their expertise in
their areas of investigation as well as for their skills in research and career mentoring.
The focus of the training remains on vascular disease and covers three major tracks: Vascular Biology,
Inflammation, and Drug Discovery; Bioengineering, Regenerative Medicine, and Vascular Imaging; and Clinical
Research related to comparative effectiveness, epidemiology, health services, clinical trials, and
implementation research. While these tracks appear to be distinct, training can be customized to incorporate
related elements of these areas. In the clinical research track, the trainees will obtain a master’s degree of
Clinical Research that is customizable to desired area of interest. Trainees in the Vascular Biology or
Bioengineering tracks are encouraged to take coursework as needed to supplement the laboratory training.
Careful selection of a team of mentors that will best support the development of each trainee will be key to the
success of the trainees.
In the first three funding cycles, the VascTrain Program was very successful in recruiting a diverse
group of trainees to the program who have demonstrated excellent productivity and retention in academic
careers with a focus on vascular research. While a number of training faculty have been involved in this
program from inception, we have recruited new faculty to bring additional expertise and evolve areas of training
to meet the changes in vascular research. New initiatives in this funding cycle include the addition of
leadership training focused on team building as well as career coaching to help trainees better evaluate career
goals and pathways to those goals. The training plan will undergo changes to better develop translational
skills, incorporate individually designed curriculum in Responsible Conduct in Research, and focus on unique
career development skills for the MD and PhD trainees. The training curriculum has also been enhanced to
include diversity training and wellness programs as well as bridging opportunities to assist in the retention of
trainees in research related career pathways.

Public health relevance
Vascular disease contributes to morbidity and mortality in Westernized cultures and worldwide but it remains underdiagnosed and poorly treated medically. The study of vascular disease greatly benefits from the involvement of physician-scientists who possess important clinical insights that inform the investigation of pathophysiology and treatment of disease and can translate this knowledge to therapies that can ultimately improve lives. The overall goal of this training grant is to support the development of such physician-scientists into skilled investigators who can drive vascular innovation and the improvement of vascular care.